Cardiovascular, Lung, and Blood Computational Library

The long-term objective of this proposal is to develop a repository of computer models of the human cardiovascular and pulmonary systems including realistic, image-based anatomic models of large arteries and airways, generic, but modifiable, models of vessels beyond the limits of imaging resolution, and blood and tissue material properties. Computer simulations using data from this repository could have significant impact in understanding cardiopulmonary pathologies, devising better diagnostic methods and therapies, and ultimately, enabling physicians to design optimal, personalized treatment plans based on predictive methods. This project will ultimately provide a critical data resource for scientists, engineers and physicians seeking to use simulation methods to aid in preventing, diagnosing, and treating patients with cardiovascular diseases.